Cancer Center Administration Core

Administration Core - Project Summary/Abstract
Dr. Reuben Shaw, PhD, serves as Director of the Salk Institute Cancer Center. He assumed this position in
December 2016 after serving as Deputy Director for two years under Dr. Tony Hunter, PhD, who was Director
2008–2016. As Director, Reuben Shaw is responsible for all aspects of the Cancer Center, including faculty
recruitment and membership, research program goals and planning, and support of Shared Resources. The
Deputy Director, Geoff Wahl, the Associate Deputy Director, Jan Karlseder, and two Associate Directors,
Suzanne Simon (Associate Director of Administration) and Tony Hunter (Associate Director of Shared
Resources) support the Director in his role. The Associate Director of Administration, Suzanne Simon, serves
as the Administrator of the Salk Institute Cancer Center and the associated NCI Cancer Center Support Grant.
This position is responsible for administrative leadership and management of all Cancer Center activities, leads
the Administrative Core Team and coordinates with all Salk Institute Administrative departments and plays a
key leadership role in grant submissions, compliance, and reporting. This position coordinates with the
External Advisory Committee and the Cancer Center Executive Committee. Along with the Associate Director
of Shared Resources, Tony Hunter, the Administrator oversees the Shared Resources. Tony Hunter provides
scientific support with the goal of maintaining a cancer-centric perspective for growth and development of the
Cancer Center supported Shared Resource Cores.